Early-life iAs exposure: diabetes and gut microbiome

ABSTRACT: PROJECT 1
Inorganic arsenic (iAs) is a ubiquitous, naturally-occurring environmental toxicant affecting over 200 million
people worldwide. Exposure to iAs has been associated with a plethora of human diseases, including diabetes,
as established in numerous animal and epidemiological studies. Growing evidence has clearly indicated that
distinct time periods of increased susceptibility to environmental exposures exist throughout the life course. The
UNC-SRP team has shown that early life iAs exposure induces glucose intolerance in mice. Meanwhile, we have
demonstrated that the gut microbiome plays a key role in iAs-induced diabetes in animal studies. Our team has
also previously shown that gut microbiome alteration is associated with iAs exposure during a critical window of
infant development in the New Hampshire Birth Cohort Study (NHBCS), a pregnancy cohort of private well users,
further highlighting the potential role of early life gut microbiome perturbation in disease development and iAs
toxicity. However, how the gut microbiome contributes to metabolic dysfunction due to early life iAs exposure
remains to be elucidated, which will be tackled by Project 1 to address a fundamental gap in understanding
mechanisms underlying early life iAs-induced diabetes. In addition, although the gut microbiome is a promising
target for intervention in human disease, there is a major gap in developing microbiome-based solutions to
protect against early life iAs-induced metabolic dysfunction. Our overarching hypothesis is that the gut
microbiome serves as a key regulator of early life iAs exposure-induced metabolic dysfunction/diabetes,
and that microbiome modulation protects against these adverse effects. To test this hypothesis, we will
pursue three specific aims: Aim 1: Examine the functional perturbations of the gut microbiome by early life
exposure to iAs and its role in iAs-induced metabolic dysfunction; Aim 2: Develop rationally designed bacterial
consortia consisting of gut bacterial species involved in arsenic detoxification and metabolic regulation to mitigate
early life iAs exposure-induced metabolic dysfunction; and Aim 3: Determine the effects of diet-based
microbiome modulation using black raspberry to protect against early life iAs exposure-induced metabolic
dysfunction. This project is led by a strong team (Drs. Lu, Sartor, Styblo, Karagas and Howe) with complimentary
expertise in arsenic toxicity, gut microbiome, iAs-induced diabetes and epidemiology. We use innovative
techniques to characterize largely unknown contributions of the gut microbiome in early life iAs-induced diabetes
and the project supports the theme of the UNC-SRP “Protecting vulnerable populations from arsenic-induced
metabolic dysfunction with a vision for exposure reduction and disease prevention.” This application is both
significant and innovative, as it will reveal the key role of the gut microbiome in early life iAs exposure-induced
metabolic dysfunction. It will also develop novel solutions to reduce iAs-induced adverse outcomes through
mechanism-guided rationally designed bacterial consortia and diet-based microbiome modulation.

Public health relevance
NARRATIVE: PROJECT 1 The proposed research is relevant to populations around the globe and the national Superfund program as it will study the role of the gut microbiome in early life inorganic arsenic-induced diabetes. Inorganic arsenic is ranked as the highest priority contaminant by the ATSDR and is affecting millions of people around the world, including vulnerable populations in North Carolina.